A Translational Research Approach to Healthy Technology Usage in Language-Minority Families with Young Children

PROJECT SUMMARY
Technology use among young children in the U.S. has become increasingly prevalent over the past decade,
and the transition to online learning during the COVID-19 pandemic has renewed concerns among parents and
educators about screen time. Recommendations for choosing high-quality apps and setting boundaries around
device use are often conveyed through position statements, white papers, and blog posts, but the information
is rarely presented in an engaging, family-friendly manner that can be readily adopted and sustained in young
children’s everyday routines. As a matter of health equity, this challenge is felt even more acutely among
language-minority households, who additionally face language barriers when attempting to access relevant
resources.
This project delivers an interactive, bilingual, hybrid virtual-and-physical world approach to address these
translational gaps. It presents recommendations from the academic and medical spheres through bilingual
storytelling and a suite of interactive, co-play activities in an online virtual world, then transitions the gameplay
to caretaker-child interactions in the physical world, empowering users to first practice healthy technology
through interactive online games and then implement those rehearsed practices in their day-to-day lives. The
effectiveness of the online platform and interactive content will be evaluated through a randomized controlled
study. Improvements in knowledge, attitudes, and confidence related to healthy technology use will be
assessed among children and their caretakers. The platform will also be evaluated for its ability to facilitate
bilingual interactions between child and caretaker that support learning and language development. Overall,
our product will serve not only as a means to inform families of best technology use practices, but as a catalyst
to broaden and reimagine joint play with digital devices especially among linguistic minority families.

Public health relevance
PROJECT NARRATIVE As highlighted in the NICHD strategic plan, technology use by children is a priority area for research as it impacts a child’s neurocognitive, behavioral, linguistic, and social-emotional outcomes. Despite ongoing efforts by medical associations and advocacy groups to provide up-to-date guidance, parents and educators continue to find it challenging to moderate children’s digital media consumption in a healthy way. This project addresses the growing need to make recommendations about healthy technology use actionable for families of diverse backgrounds through bilingual storytelling, interactive games, and co-play in order to translate guidance into everyday routines.